The effect of local virus infection upon cutaneous wound healing: the impact of virus-induced Type III IFNs

SUMMARY
The skin, with its surface area of approx 1.8m2, is one of the largest organs in the human body and is the most
exposed to the environment. Maintenance of the skin barrier is of paramount importance to prevent infection by
commensal or pathogenic bacteria, or other pathogens. However, study of the mechanisms of wound healing
has been conducted primarily in the context of sterile wounding, and has never been conducted in the context
of cutaneous virus infection, the focus of this proposal. A significant number of viral pathogens, such as
papillomaviruses, some herpesviruses and some poxviruses, infect cutaneously and are responsible for infection
of hundreds of millions of people worldwide. These viral infections can often induce a strong local immune
response that differs from the response that is normally induced during sterile wounding. The paradigm of tissue
renegeration is that wound healing only begins after clearance of a pathogenic infection. However, our
preliminary data indicates that a wound healing response begins prior to the peak of cutaneous virus replication.
Therefore, the antiviral response that aims to clear the virus can likely both enhance and oppose individual
components of the highly regulated wound healing process that is occurring concurrently. Our preliminary data
indicate that wound healing after cutaneous virus infection, which is crucial to prevent secondary bacterial
infections, displays a number of crucial differences to sterile wounding. These differences include the
composition of the cellular response, and the effects of antiviral molecules, such as interferons, upon wound
healing. In Specific Aim 1 we will establish a new system to directly and systematically examine the effects of
the local virus infection upon the molecular and cellular wound healing response. In this way we will identify key
regulators of the antiviral response that also impact cutaneous healing. In Specific Aim 2 we will establish a
pipeline to test these key regulators by investigating the role of Type III interferons (T3-IFN), which our
preliminary data indicate are strongly induced only upon virus infection, as a candidate regulator of wound
healing in our pipeline. T3-IFN are required for effective wound healing, but not control of virus replication. T3-
IFN are a family of cytokines that are primarily produced at barrier surfaces, such as gut, lung and blood brain
barrier. T3-IFNs can have a large number of downstream effects independent of control of virus growth, including
control of the cell cycle as well as recruitment and modulation of the activation of innate and adaptive immune
cells. The localized nature of T3-IFN production makes them a promising therapeutic target, as they can be
administered, or their action modulated, without the need to account for systemic side effects. We will examine
the role of previously identified T3-IFN-induced molecules, and identify additional T3-IFN-modulated regulators
of cutaneous wound healing. We will then be poised to expand our studies, both to further understand how T3-
IFN modulates wound healing at the molecular level, but also to investigate the role of other molecules and cell
populations induced by cutaneous virus infection in the wound healing response, in a future RO1 proposal.

Public health relevance
Narrative Maintenance of the skin barrier is of paramount importance to prevent infection by commensal or pathogenic bacteria, so a highly regulated process occurs to close wounds as quickly and effectively as possible to prevent infection. Many viral pathogens infect the skin, but the mechanisms of wound healing have not been examined in the context of cutaneous virus infection. Here we will establish a systematic approach to identify changes in wound healing mediated by the antiviral response and test a pipeline, focusing upon Type III interferons, to examine the mechanistic role of candidate molecules in virus-modulation of wound healing.